PARTIAL MENISCECTOMY VS. NONOPERATIVE MGMT. IN MENISCAL TEAR WITH OA: AN RCT

Symptomatic knee osteoarthritis (OA) affects over 14 million people in the US, ~ 70% of whom have meniscal
tear. About 400,000 arthroscopic partial meniscectomies (APM) are performed for OA and meniscal tear
annually. Although patients live with OA for decades, research on treatment of meniscal tear in patients with
OA (physical therapy (PT) or APM) has focused on the first 2 years following treatment. Consequently, there
has been little research on the effect of APM or PT on progression of pathologic changes in cartilage, bone,
synovium, and other structures.
Two especially salient questions remain unanswered about the long-term outcomes in this patient population,
and both will be addressed in this proposed 12-year follow-up of subjects in the MeTeOR (Meniscal Tear in OA
Research) Trial. First, our preliminary data from MeTeOR, which compared outcomes of APM and PT, suggest
APM is associated with more rapid structural progression through 5 years. It is critical to determine whether
these effects of APM on OA progression are borne out with longer follow-up, as they are essential for informed
discussions about benefits and drawbacks of APM and nonoperative therapy. A more profound research gap is
the uncertain clinical interpretation of structural changes on MRI. While clinicians and investigators assume
that rapid structural progression of OA results in more severe pain over the long term, there is scant evidence
supporting this claim. MeTeOR subjects underwent MRI at baseline, 18-, and 60-months following enrollment,
providing a unique opportunity to assess 12-year clinical consequences of structural progression. We propose
the following aims:
1. Conduct 12-year follow-up of MeTeOR subjects to characterize the extent of cartilage damage over 12
years and identify factors, including treatment with APM vs. PT, associated with more rapid progression.
2. Assess whether the extent of progression in structural damage over the first 5 years post-treatment in
persons with OA and meniscal tear predicts worse symptoms and functional status at 12 years.
Successful completion of these Aims will provide clinicians and their patients with crucial data to facilitate
informed decisions about treatment for meniscal tear and OA. This work will also test the foundational
assumption that structural progression in OA leads, ultimately, to pain and functional limitation.

Public health relevance
The MeTeOR Trial compared outcomes of surgery and PT in subjects with painful meniscal tear and osteoarthritis. This study will follow MeTeOR participants out to 12 years of follow-up to address two key questions that affect the health of millions of Americans: whether surgical therapy is associated with faster progression of osteoarthritis, and whether faster progression is associated with worse pain outcomes at 12 years.